Research Opportunities for Undergraduates: Training in Environmental Health Sciences (ROUTES)

SUMMARY. Objective: The objective of “Research Opportunities for Undergraduates: Training in
Environmental Health Sciences (ROUTES)” renewal is to build on a decade of success to inspire
and develop undergraduate students from underrepresented minority (URM) backgrounds to
pursue careers as scientists, engineers and other related researchers in environmental health (EH)
fields. We are driven by the importance of EH outcomes for disproportionately affected URM
communities, the lack of representation of URMs in EH fields, and the complex, collaborative and
interdisciplinary nature of EH research. Specific Aims: (1) Identify and build relationships to attract
students to EH research opportunities at NU and beyond, (2) Engage and train Northeastern
undergraduate students in EH research through co-operative education experiences on-campus in
faculty research labs, and in external partner research settings, and (3) Promote mentoring and
build community among ROUTES student participants and faculty mentors through a robust
program of EH-related training activities. Approach: ROUTES provides basic and translational
research experiences in EH disciplines that leverage Northeastern’s (NU) well-known cooperative
education (co-op) structure. Our program’s participating faculty and external partners provide
mentoring and research experiences in health sciences, engineering, environmental sciences, and
environmental justice and policy fields through: (1) full-time, paid co-op research experiences for
six months for selected URM students (ROUTES Scholars), (2) targeted mentoring and support
services to assist URM student participants in pursing graduate studies and research careers, and
(3) cohort building and professional development. We have increased the number and types of
supported experiences through the addition of off-campus research partners in addition to on-
campus EH faculty, and cost-sharing with faculty mentors for student salary. We will develop an
accompanying credit-bearing course on research methods and EH careers specifically designed for our
ROUTES Scholars. ROUTES will build upon connections to campus URM affinity groups and
existing NIH-funded programs for robust and meaningful recruitment and networking. The program
evaluation plan includes well-designed assessment and continuous improvement to maximize
efficacy. Expected Results: ROUTES will enlarge the pool of undergraduate URM students that
are interested in exploring EH research careers and create opportunities for up to 60 students over
five years to participate in paid hands-on research experiences, mentoring, and complementary
activities. Through these methods, ROUTES will continue to continue its long history of
encouraging URMs to pursue research careers in EH, thus addressing a critical national need.

Public health relevance
PROJECT NARRATIVE Through targeted one-on-one mentoring between researchers and undergraduate students from communities underrepresented in the environmental health (EH) fields, ROUTES seeks to increase engagement of underrepresented minorities (URMs) in the increasingly complex field of EH research. ROUTES continues a decade-long, multidisciplinary program centered around placing students in meaningful, paid, cooperative work experiences on EH research projects with campus-based faculty and external research partners. Through integration with existing campus P42 and T32 training programs and other EH funded projects, ROUTES will provide training, professional development, and networking opportunities to encourage URM students to pursue research and related careers in EH.